2015 North American Association of Central Cancer Registries Annual Conference

? DESCRIPTION (provided by applicant): The goal of this application is to convene a conference which will launch a new collaboration between cancer surveillance and cancer researchers to maximize the use of cancer registries in advancing our scientific understanding. NAACCR has hosted the most influential and informative annual conference for cancer surveillance scientists in North America for the last 27 years. The NAACCR Annual Conference is attended by approximately 400 scientists from across North America drawing from all population-based central cancer registries, cancer surveillance organizations and universities. It is the largest meeting of its kind for population-based cancer registries to participate in the advancement of cancer surveillance science, learn new techniques, exchange information, and develop efficient and cost-effective work practices. This year we are placing an emphasis on integrating cancer surveillance more closely with advances in cancer biology in order to make cancer registries more useful to researchers. The objective of this conference grant is to: Convene a conference for North American cancer researchers to demonstrate how advances in cancer surveillance research and methods will launch a new era of research in cancer biology, epigenetics and clinical care. This conference is relevant to the NCI mission by enhancing the connection between cancer surveillance and researchers to leverage new knowledge. Cancer surveillance data (i.e. SEER data) forms the backbone of countless cancer research studies each year. The methods used will be the planning and implementation of a world-class scientific conference, with workshops, break-out sessions, panel discussions keynotes, plenaries, and posters. Opportunities for class room learning, lecture, sharing of scientific results, debate and networking will play an important role in achieving the objective. In addition, we plan to encourage attendance and enhance diversity by subsidizing registration for delegates from under-resourced countries. This conference provides an excellent opportunity for participation by groups that are often underrepresented in science, namely women and minority groups. Women make up the majority of delegates at NAACCR meetings and representation comes from every state and province in North America.

Public health relevance
PUBLIC HEALTH RELEVANCE: The NCI established the Surveillance Epidemiology and End Results (SEER) Program to monitor cancer rates and trends in the US and to serve the research community by providing information across the US and over time. SEER has been the gold standard in cancer surveillance since its inception in the early 1970s and has provided the foundation for the Cancer Statistics Review (1) publications for decades, is the source of data for SEER-Medicare matches, and has been the foundation of thousands of analyses of cancer in the US and around the world. To ensure standardization and comparability of cancer data across North America, the NCI and other partners, including the North American Association of Central Cancer Registries (NAACCR) worked collaboratively to establish best practices and sound methodology for data evaluation, aggregation and analysis of data from central cancer registries beyond the SEER Program which makes possible such publications as the Annual Report to the Nation (4- 18), a series of publications that are the most widely cited by NCI scientists. Cancer surveillance data are an essential tool for researchers throughout the world to assess cancer in the population, and supplements data obtained in the clinical setting. Cancer surveillance data provide the foundation for research in epidemiology, population science, cancer control evaluation, cancer survival, comparative effectiveness and clinical care. We are on the frontier of a new age of discovery in cancer biology and cancer registries will play a fundamental role by providing the essential link between the clinical environment and population science. For more than 25 years NAACCR has hosted the most influential and informative annual scientific conference for cancer surveillance scientists. Drawing from every state and province in North America, the NAACCR Annual Conference is attended by approximately 400 researchers, epidemiologists, and cancer surveillance scientists annually. Developed by and for cancer surveillance professionals it is the largest meeting of its kind to share research findings, develop innovative methodologies and support a variety of cancer research endeavors. Please note, that since this conference is solely focused on cancer, we have not sought co- sponsors from other NIH centers.